MECHANISMS OF METALLOPROTEINASE EXPRESSION BY OXIDANT STRESS

Injury to the kidney by a variety of stimuli may be associated with an acute inflammatory self-limiting process or it may progress with a chronic inflammatory response leading to fibrogenesis, tubular and glomerular obsolescence and eventually severe impairment of renal function. Some of the mechanisms by which a persistent inflammatory response leads to fibrogenesis and progressive renal failure are not completely understood. Neutrophil activity seems to be associated with endothelial damage and is part of the inflammatory response coordinated by a network of inflammatory cytokines and chemokines that are clearly involved in part of this process. Some of the molecules include interleukin-1beta, tumor necrosis factoralpha, and interleukin-6. In addition to these lymphokines and chemokines, there is the potential for the generation of reactive oxygen intermediately which are part of the processed involved in injury to the kidney The major oxidant species which have been implicated in renal injury are superoxide, hydrogen peroxide, and the hydroperoxy radical. In addition it has become recently obvious that other oxidant species which have some relevance to a progressive renal injury is the generation of peroxynitrite.. We believe that the respiratory burst oxidase which is the major extra mitochondrial site for the generation of superoxide is an important feature of these inflammatory responses. Products of the respiratory burst oxidase are capable of signaling through a variety of signal transduction process leading to the activation of a number of pro- inflammatory genes, which may have significant influence on the outcome of a renal inflammatory process. This grant, therefore, proposes to assess the role of novel matrix metalloproteinase (MMP-13), which was initial identified and associated with breast cancers. We have shown that inflammatory cytokines are capable of inducing and dramatically up- regulating this matrix metalloproteinase which may be important and relevant to the regulation of extracellular matrix proteins. This proposal seeks to examine some of these interactions and the regulatory features which may influence the activity of this matrix metalloproteinases and its inhibitors.